Impacts of drug abuse-mediated inflammatory perturbations on affinity maturation of anti-CD4 autoantibodies and poor immune reconstitution from ART in HIV

ABSTRACT
This resubmitted proposal is in response to RFA-DA-25-012 (reissue of RFA-DA-24-003) for “Antibody-
mediated enhancement of HIV infection/replication following B-cell responses can result in depletion and blunted
recovery of CD4+ T-cells and poor immune recovery despite suppressive ART. How these immune components
in the context of HIV infection and substance use disorder contribute to the pathology of both conditions
represents a significant knowledge gap. Studies focused on inflammasome cascades and pathogenic antibodies
mediated by chronic drug use and HIV infection are warranted”. About 25% HIV patients under anti-retroviral
therapy (ART) fail to recover CD4+ T cell counts to a level comparable to healthy people. Because CD4+ T cell
is critical for immune response to foreign pathogens, it is critical to develop new medications to recover CD4+ T
cell counts to reduce co-morbidity and mortality in HIV. Our preliminary studies reveal anti-CD4 autoantibodies
to be increased in HIV+ drug abusers and to play a key role in inducing CD4+ T cell death. How cocaine
(proinflammation) and cannabis (anti-inflammation) use affect B cell function, pathogenic anti-CD4 autoantibody
development, and CD4+ T cell recovery from ART in PWH remains unclear, thus, we propose two aims here:
Aim 1. Determine mechanisms of affinity maturation and CD4 recognition for anti-CD4 autoantibodies presenting
ADCC activity in HIV+ drug users.
Aim 2. Determine drug use-mediated B cell perturbations, anti-CD4 autoantibody production, and HIV
immunopathogenesis.

Public health relevance
PROJECT NARRATIVE In our published work, we are the first group to determine that anti-CD4 autoantibodies increase in HIV+ drug- abusers and contribute to altered HIV reservoir and poor CD4+ T cell recovery from suppressive ART by inducing CD4+ T cell death via antibody-mediated cytotoxicity (ADCC). However, how drug-induced inflammation facilitates the development of anti-CD4 autoantibodies and the mechanisms of HIV pathogenesis modulation by anti-CD4 antibodies remain poorly understood. In this proposal, we will isolate monoclonal anti-CD4 antibodies and elucidate the molecular and cellular bases of autoimmunity-mediated poor immune recovery observed in ART-treated HIV+ drug abusers, which will provide information on therapeutic strategies to prevent autoimmunity in HIV pathogenesis.